Operationalizing Behavioral Theory for mHealth: Dynamics, Context, and Personalization

Abstract
This Administrative Supplement expands on the Specific Aims of the parent U01 award by proposing to
harmonize data across the Micro-Randomized Trials (MRTs) involved in the Intensive Longitudinal Health
Behaviors Network (ILHBN) to study engagement in digital trials and just-in-time interventions. This parent
project (HeartSteps II, U01CA229445) is part of the ILHBN, established to collaboratively study factors that
influence dynamic health behaviors in individuals’ daily lives using intensive longitudinal data (ILD) collection
and novel analytic methods. The network includes seven U01 projects and one U24 Research Coordinating
Center (RCC). The effectiveness of digital interventions is heavily reliant upon the participant’s engagement with
the digital behavior change intervention (DBCI). To achieve behavior change, the participant needs to engage
with the interface components of the DBCI app (e.g., app page views, logins), as well as the behavior change
techniques (e.g., activity planning, weight-logging, diary entries) employed in the DBCI. There are tremendous
opportunities to advance theory-driven behavior change interventions by sharing and analyzing ILD across the
ILHBN network interventions. To maximize the utility of these data to advance the science of mobile health
engagement and to support researchers interested in developing and testing new methods for analyzing
complex, real-world behavioral data, we propose an Administrative Supplement that augments the work of the
parent grant with the following new specific aims; 1): Curate and share data, paradata, and metadata with
members of the ILHBN, and 2) Operationalize and Model Engagement in JIT interventions. This project
will the first to investigate the patterns and correlates and causes of changes in engagement in Just-In-Time,
mobile interventions over time. It will also support the curation of data to be contributed to the ILHBN flagship
database. These data will support the development of models with the potential to lead to insights about a range
of dynamic behavioral processes including engagement with mobile technologies in general. Finally, this
Supplement will support the development of dynamic computational models of engagement in JITAIs and the
tools to run them. Together, these activities move the field of ILD and engagement with ILD and JITAIs forward
substantially.

Public health relevance
Project Narrative This administrative supplement will support the development of an unprecedented IDL dataset built from data across the Intensive Longitudinal Health Behavior Network (ILHBN) studies, and will support groundbreaking theoretical work, dynamic modeling of behavior and the development of modeling tools. We will curate and share Ecological Momentary Assessment and fitness tracker (FitBit) data, paradata and metadata from the parent project with the seven member projects of the ILHBN. It will also support Operationalizing and Modeling Engagement in JIT interventions (i.e. engagement with the app and engagement with intervention). Participants’ engagement is essential to the effectiveness of any intervention. We will collaborate with the one other study in the ILHBN that is also a Just-in-Time, Adaptive Intervention to harmonize our data to inform research on how the history related to both self-report and intervention explains and predict engagement in JIT interventions.